Community Engagement Core

Project Summary/Abstract
Community Engagement Core
Community engagement in cardiometabolic disease research is critical to further awareness and identification
of disparities to develop appropriate and feasible interventions. The UC END DISPARITIES Community
Engagement Core (CEC), in collaboration with a diversity of community stakeholders embedded in all Center
activities, aims to promote cardiometabolic disease research that is reflective of community priorities, elevates
sociocultural sensitivities, and is feasible, action-oriented, and translatable to communities. The CEC
Community Action Board (CAB) will incorporate community expertise, including lived experience, knowledge of
needs and assets, and awareness of sociocultural sensitivities that is critical for developing successful
processes, and conducting meaningful research. CEC will work through strategic community-academic
partnerships, near-peer leadership development, structured action-based capacity building processes, and a
dissemination-as-action paradigm to partner with diverse communities, develop innovative research,
disseminate findings, and make policy recommendations for systematic change to achieve health equity. The
CEC infrastructure prioritizes near-peer bidirectional and cross-disciplinary academic-community partnership
capacity building to develop the next generation of academic and community-based experts in community-
engaged cardiometabolic disparities research. The CEC will provide critical community perspectives in
selecting and reviewing the pilots and community catalyst awards, provide feedback on project materials for
inclusion in projects, and support community-engaged research processes for pilot projects. Finally, the CEC
will utilize and enrich an already strong foundation of pre-existing community relationships and community
engagement mechanisms, including leveraging resources from highly successful community partnerships—
between researchers, clinicians, community-based organizations, and residents—to spur discovery, new
approaches to prevention, and the development of effective clinical and policy interventions to reduce risk,
morbidity, and mortality of cardiometabolic conditions in diverse multiethnic communities.